Therapeutic Targeting of NSD2 in Lung Adenocarcinoma

ABSTRACT
Our overarching goal is to evaluate the therapeutic potential and mechanism-of-action of the epigenetic
regulatory factor NSD2 in lung adenocarcinoma (LUAD). Lung cancer is the most common cause of cancer-
related mortality in the United States and worldwide, leading to over a 1.8 million deaths each year. LUAD is its
most common histological type of lung cancer. While new targeted and immunotherapies have improved median
survival for LUAD patients, unfortunately, improvement in outcomes over the past 20 years has been
incremental. Thus, there is great interest in identifying novel factors that might cooperate with the canonical
oncogenic pathways that drive LUAD with the notion that a therapeutic strategy hitting multiple pathways will
mitigate potential drug toxicity by lowering the overall dose needed for each medicine and in parallel combat
resistance development. A central hypothesis to be tested here is that the clinically actionable and histone lysine
36 (H3K36) di-methyltransferase enzyme NSD2 is such a factor. In preliminary work we found that NSD2
promotes aggressive malignant tumor progression and rapid lethality in a classis LUAD mouse model. In our
proposal, we will investigate the molecular, epigenetic, cellular, and in vivo role of NSD2-H3K36me2 axis in lung
cancer and directly test the efficacy of NSD2-targeted therapy using a first-in-class NSD2 inhibitor and state-of-
the-art pre-clinical models of LUAD.
In Aim 1 we investigate the role of NSD2 in lung cancer pathogenesis. We have developed a KRASG12C-
driven NSD2 tunable mouse lung cancer model to investigate the function and mechanism of action of elevated
or depleted NSD2 activity in LUAD initiation, progression, metastasis, and intratumoral heterogeneity. In Aim 2
we evaluate therapeutic efficacy of NSD2 inhibition using a first-in-class potent inhibitor of NSD2. We will utilize
genetic models such as LUAD driven by KRASG12C mutations and multiple patient derived LUAD xenografts to
test anti-tumor efficacy of NSD2 inhibition as a single agent and as part of combination therapies. Together, this
work will be the first to evaluate the therapeutic potential and mechanism-of-action of NSD2 in LUAD.

Public health relevance
PROJECT NARRATIVE We propose to investigate the mechanisms of action of the NSD2 methyltransferase in mammalian cells, including elucidating its biochemical and functional activity and by testing the first-in-class NSD2 inhibitor in treatment of lung cancer cells in culture and in vivo.